Circadian regulation of brain and body in larval zebrafish

Project Summary
Circadian rhythms drastically alter animal behavior through diverse actions on cellular targets throughout the
body. Disruptions of sleep-activity cycles account for a wide range of diseases affecting behavior, neurology,
metabolism, and muscle physiology. This proposal presents a set of studies designed to understand the
mechanisms and interactions of circadian effects on cells and systems spanning the body. Circadian rhythms
manifest downstream of pacemakers via signaling molecules that act directly on targets to regulate physiology.
Understanding how distinct targets are modified to achieve a constellation of physiological and behavioral
rhythms is a major goal in chronobiological research. We study how neurons, muscles, and biomechanics
interact in larval zebrafish, a tractable diurnal vertebrate, and our preliminary experiments suggest these animals
experience a breadth of circadian changes far more diverse than previously known. Although the zebrafish is an
imperfect model of sleep behavior, its clear circadian rhythms combined with its tractability for physiological,
behavioral, and genetic approaches make it an ideal system for understanding how circadian rhythms organize
and interact across cells and organs. The original proposal aims to define how diverse circadian effects on
nervous system output and muscle physiology amount to complex behavioral output, by tracking and modeling
zebrafish behavior and arousal across the diel cycle. Here we request resources to complement institutional
support for a multiphoton microscope, which affords activity measurements using invisible light, thereby
facilitating comparisons of physiology across circadian time without the confounding effects of measurement
approaches that use visible light. Together these experiments will provide detailed information and models
regarding the interaction of circadian effects across cells and systems.

Public health relevance
Project Narrative Disruptions of sleep-activity cycles account for a wide range of diseases affecting behavior, neurology, metabolism, and muscle physiology. Circadian rhythms drastically alter animal behavior through a diversity of actions on cellular targets throughout the body. We aim to measure physiological changes across circadian time using invisible microscopy methods that do not arouse subjects.